Identification of therapeutic vulnerabilities in prostate cancer bone metastasis

Project Summary/Abstract
Prostate cancer lethality is mainly due to metastasis, which occurs most frequently in bone and is
associated with high morbidity. Despite recent progress, current treatments are not curative and therefore new
therapeutic strategies are urgently needed. Given that both metastatic progression and therapeutic resistance
occur in the context of a whole organism and are influenced by the tumor microenvironment, one significant
challenge to our current understanding of metastatic progression is the paucity of models in which to study
metastasis in its physiological context, and especially models that recapitulate the bone tropism of human
prostate cancer.
The overarching goal of this proposal is to understand how the molecular alterations present in lethal
prostate cancers contribute to disease outcome and how to use this knowledge to develop more effective
therapies. In particular, my preliminary data strongly suggests MYC as a driver of bone metastasis progression.
Given that MYC has traditionally been hard to target therapeutically, this proposal will leverage unique mouse
models of bone metastasis to address specific therapeutic vulnerabilities to target MYC signaling dependencies
in prostate cancer. Specifically, in Aim 1 I will study small molecule inhibition of the ATAD2-bromodomain as a
strategy to inhibit metastasis and therapy resistance. In Aim 2, I will use CRISPR screens to identify synthetic
lethal vulnerabilities of prostate tumors with high MYC activation. In Aim 3, I will exploit CRISPR technology to
somatically edit the genomes of mouse prostates in order to streamline the study of the phenotypic
consequences of genetic alterations for prostate cancer progression.
The career development plan outlined in this award leverages my training at Columbia University and an
outstanding advisory committee into an innovative research plan to steer my career into specific precision
medicine approaches for the treatment of prostate cancer bone metastasis. This proposal will provide the
conceptual groundwork, preliminary data and experimental tools for a competitive R01 submission, thus
launching my independent career.
If successful, this award will provide proof-of-principle for a new class of targeted agents and uncover
new therapeutic vulnerabilities in metastatic prostate cancer as occurs in vivo. This proposal will advance the
field by potentially leading to novel clinically testable hypotheses that may guide clinical trials. Ultimately, these
results will impact patient care by reducing the morbidity and mortality associated with metastatic prostate
cancer.

Public health relevance
Project Narrative Metastatic prostate cancer is the second-leading cause of cancer-related deaths in men, ranks third in national cancer expenditures and represents significant morbidity to patients due to bone metastasis and side effects of treatment. This proposal will perform preclinical studies to identify previously unrecognized therapeutic vulnerabilities of prostate cancer bone metastasis and treatment-resistant tumors. These studies may ultimately result in novel treatments that can potentially improve survival and reduce morbidity of this lethal disease.